ASSOCIATION OF CAMPYLOBACTER PYLORI INFECTION WITH GASTRODUODENAL INJURY

Study of rheumatoid arthritis patients on chronic nonsteroidal antiinflammatory campylobacter pylori therapy for associated cp infection.